8/8 NADIA U01 Long-Term Effects of Adolescent Alcohol on Pain

Adolescent alcohol use leads to persistent neural adaptations and behavioral dysregulation that increase the
risk of developing alcohol use disorder (AUD). Acute alcohol reduces pain, and chronic pain (e.g., hyperalgesia)
can promote alcohol drinking through negative reinforcing analgesic effects. Paradoxically, chronic alcohol
produces hyperalgesia or worsen pre-existing pain states. Recently, we reported that medial central amygdala
(CeA) projections to a midbrain region called the periaqueductal gray (vlPAG) are critical for mediating
hyperalgesia in chronically alcohol exposed adult male rats. This chronic alcohol weakens synaptic connectivity
between medial CeA and vlPAG in adult male rats, photostimulation of the CeA-vlPAG circuit rescues
hyperalgesia in alcohol-dependent adult rats, and photoinhibition of this circuit produces hyperalgesia in naïve
rats. Our lab and others find that antagonism of corticotropin-releasing factor type-1 receptors (CRFR1) in CeA
reduces hyperalgesia associated with alcohol withdrawal, nicotine withdrawal and traumatic stress in adult rats.
Our overarching hypotheses are that chronic intermittent alcohol exposure in adolescent rats (AIE) produces
persist long-term effects on polymodal (i.e., mechanical and thermal) hyperalgesia that is mediated by weakened
CeA-vlPAG connectivity and increased CRFR1 signaling in CeA. The CRFR1 signaling gating of CeA-vlPAG
function is important for mediating AIE-induced hyperalgesia.
We include preliminary data showing that 1) AIE produces rapid and long-lasting thermal and mechanical
hyperalgesia during adolescence and that this effect persists into adulthood (Fig. 1), 2) AIE reduces synaptic
drive and excitatory/inhibitory ratio on vlPAG-projecting medial CeA neurons in adulthood (Fig. 3), 3) CRFR1 is
expressed on vlPAG projecting cells (Fig. 2), and 4) validation data for a CRFR1:cre rat for CRFR1+ cell type-
specific modulation of CeA outputs (Fig. 4). Because we also propose to challenge rats with a short-lasting
inflammatory pain challenge in adulthood, we have also piloted dose-response effects of carrageenan on
nociception in adult Wistar rats. Here, we propose aims that will test the hypotheses that AIE produces
hyperalgesia during adolescence that persists into adulthood (Specific Aim 1), that AIE reduces synaptic drive
and excitatory/inhibitory balance of synaptic transmission onto vlPAG-projecting CeA neurons via a CRFR1-
dependent (Specific Aim 2), and that pharmacological, circuit-based, and epigenetic modulation of CRFR1+
PAG- projecting CeA neurons will rescue AIE-induced hyperalgesia and CeA-vlPAG circuit plasticity (Specific
Aim 3). Importantly, we propose specific collaborations with Research Component 6 (PI:Chandler) and 5 (PI:
Crews) along with the Epigenetics Core (PI: Pandey) of the NADIA consortium. This proposal focuses on testing
adolescent alcohol effects on pain-related outcomes and aligns with the overall goal of the NADIA consortium to
examine the effects of adolescent alcohol exposure on the adult organism.

Public health relevance
Project Narrative Adolescent alcohol use leads to long-term neural and behavioral changes, and it is known that chronic alcohol exposure in adults increases pain. The current proposal will test the effect of chronic alcohol exposure during adolescence on long-term pain outcomes and will work to identify the neurobiological mechanisms underlying those effects. Our proposal uses behavioral pharmacology, slice electrophysiology, epigenetic analysis, and circuit-based approaches to test the role of specific amygdala peptide systems in mediating heightened pain in individuals with a history of adolescent alcohol exposure.